Skeletal Muscle Nrf2: Exercise-Induced Cardiovascular Protection

PROJECT SUMMARY
The goal of this study is to elucidate novel mechanisms underlying exercise training (ExT)-induced sympatho-
inhibition in chronic heart failure (CHF) (Aim 1) and cardioprotection following acute coronary
ischemia/reperfusion (I/R) (Aim 2), based on an innovative concept of inter-organ transfer of antioxidant
enzymes. It is well established that exercise generates muscle-derived reactive oxygen species (ROS) which
activates nuclear factor (erythroid-derived 2)-like 2 (Nrf2), resulting in upregulation of a panel of antioxidant
enzymes in skeletal muscle per se. We hypothesize that these antioxidants can be transported from skeletal
muscle to remote tissues through circulating extracellular vesicles (EVs), providing recipient cells with a
second and enhanced line of antioxidant defense. In the rostral ventrolateral medulla (RVLM) of mice with
CHF, these antioxidants restore redox homeostasis of pre-sympathetic neurons, contributing to ExT-sympatho-
inhibition. Furthermore, in the heart of mice subjected to coronary I/R, these antioxidants reduce free radical
damage and salvage ischemic myocardium, thus playing a critical role in ExT-cardioprotection. To address
these hypotheses, we developed three skeletal muscle-specific transgenic mouse lines. The MS-mG line is a
reporter model, which allows us to track, capture, and analyze EVs released specifically from skeletal muscle.
This model will be used to assay cargo proteins of skeletal muscle-derived EVs and their distribution in brain
and heart following ExT. The iMS-Nrf2flox/flox and iMS-Keap1flox/flox lines will enable us to delete skeletal muscle
Nrf2 (i.e. Nrf2 deficiency) and Keap1 (i.e. Nrf2 overexpression), respectively. These two models will be used to
demonstrate a causal relationship between the Nrf2/antioxidant system and ExT-sympatho-inhibition in Aim 1
and ExT-cardioprotection in Aim 2. Interdisciplinary methods of EV biology, proteomics, bioinformatics,
electrophysiology, and cardiovascular physiology will be utilized to characterize skeletal muscle-derived EVs
following ExT, determine the effects of ExT-EVs on central neuron discharge and peripheral sympathetic nerve
activity, and explore the mechanisms underpinning cardioprotection of ExT-EVs against coronary I/R injury.
Upon completion of this project, we expect to provide novel mechanistic insights on ExT-cardiovascular
protection, paving a new avenue to translate the beneficial effects of regular physical activity into clinical
practice to prevent and treat acute and chronic ischemic heart diseases.

Public health relevance
PROJECT NARRATIVE The proposed studies will determine the mechanisms for beneficial influences of regular physical activity on brain and heart. We will identify protective factors released from muscle during exercise that can travel to these two vital organs to restore central autonomic function in chronic heart failure and protect the heart following an acute reduction in blood flow.